UCSD Alzheimer's Disease Research Centers P30

OVERALL – SUMMARY/ ABSTRACT
Alzheimer’s disease and related dementias (ADRD) together constitute a paramount and growing public
health issue with tremendous cost and unfathomable aggregate suffering. Unless the diseases can be
effectively treated or prevented, increased prevalence with changing demographics will lead to costs the
country will find difficult to bear. Reflecting this national imperative, the National Alzheimer’s Project Act
(NAPA) created a roadmap and goal to impact this disease by 2025. The current proposal for renewed funding
of the UCSD Shiley-Marcos Alzheimer’s Disease Research Center (ADRC) explicitly aligns with NAPA and
leverages the center’s deep roots and engagement built over the past 35 years. The center’s rich academic
and community environment make it well positioned to synergize with the ADC network toward achievement of
NAPA goals and milestones, particularly along the theme of examining heterogeneity of ADRD through the
study of models, markers, and mechanisms in a diverse cohort of volunteers. Specifically, the center proposes
work that will bring world-class advanced translational neurosciences to the study of heterogeneity and
diversity in ADRD using new models and new, tailored community engagement approaches. including
innovative disease in a dish models fostered by its new iPSC Core, and increased engagement with the Latino
Amerindian community through the establishment of a Latino Core. Efforts are tightly integrated with functions
of other cores bolstered by tremendous resources and experience gained over the center’s longstanding
existence, while incorporating the most innovative, disruptive and cutting-edge science available on the multi-
faceted UCSD campus. The center will achieve the following overarching aims unifying its broad-based activity
in research, education, engagement, and sharing and synergizing with the ADC network: The center will 1)
apply well-developed and interactive cores to foster cross-disciplinary, integrative, and innovative clinical and
translational science, 2) educate and train a diverse workforce, 3) Provide a hub for scientific and community
exchange and support, optimizing core efforts and synergies to best serve the local and broader patient,
caregiver, and research communities and 4) engage in collaborative research across centers, with special
emphasis on applying center strengths to complement the ADC network and extend its impact.

Public health relevance
OVERALL - NARRATIVE The medical field lacks therapies for Alzheimer’s disease and related dementias (ADRD), and success in their development will depend on the application of team-based science incorporating new ideas and the smartest, most creative investigators asking questions relevant to a diverse population. The Shiley-Marcos Alzheimer’s Disease Research Center coordinates activities to foster this science, engage the community, and educate the next generation of brilliant, creative, and diverse investigators.